Design and Development of an Advanced Functional MRI Software as Medical Device (SaMD) forClinical Trials and Therapeutic Applications in Neuropsychiatry

ABSTRACT
Neuropsychiatric conditions comprise a significant portion of global disease burden, yet
approval rates for novel therapies remain low. This stems from a continuing lack of evidence
from human subjects on neurobiological target engagement and mechanisms of action, which
leads to exorbitant costs and risk of clinical trial failure that together impede successful market
entry of effective treatments. Functional magnetic resonance imaging (fMRI) has been a
transformative tool for human systems neuroscience, which over 20 years has revealed the
functional architecture of the brain in health and disease. It has the potential to support the
creation of new treatments for neuropsychiatric disorders with objective biological evidence of
treatment effects. In practice, commercial deployment of fMRI has been limited due to enduring
challenges related to artifacts, processing, and result reproducibility. To realize its potential,
there is a need for a fMRI platform that meets clinical trial and industry requirements for
standardization. To address this need, Ceretype Neuromedicine proposes to develop an end-to-
end advanced fMRI platform focused on improving sensitivity, reliability, and automation for
industry-sponsored trials of neuropsychiatric therapies. This innovative solution builds on our
well-validated multi-echo fMRI (ME-fMRI) approach, multi-echo independent component
analysis (ME-ICA), which alone quadruples signal-to-noise, doubles statistical power, and triples
the time efficiency of fMRI exams. Ceretype has now deployed this technology in commercial
clinical trials of novel therapeutics and in exclusive partnership with a leading imaging contract
research organization. Here, we propose extensive engineering and testing around ME-ICA for
a single, automated pipeline that meets rigorous standards for reproducibility and
standardization through FDA 510(k) clearance of a class II software as a medical device. New
features will support integration into a wide array of clinical trial environments and
corresponding radiological workflows. We also introduce a new quantitative metric of brain
activity, which our preliminary evidence suggests controls for unwanted measurement variability
that impacts multi-site studies. The two primary objectives of this fast-track SBIR proposal are to
1) engineer a fMRI system for industry-backed trials that meets regulatory requirements (Phase
I), and 2) establish standard quantitative fMRI measurements with regulatory guidance, validate
the system, and submit to the FDA for 510(k) clearance (Phase II). In Phase I, we aim to
conduct design and development around standardization requirements (IEC 62-304, ISO 13485,
21 CFR 820, ISO 14971) and then design and execute verification tests to meet product
requirements. In Phase II, we aim to design standard quantitative fMRI measurements with
regulatory guidance (FDA’s Technical Performance Assessment of Quantitative Imaging in
Radiological Device Premarket Submissions), and conduct validation testing prior to submission
for 510(k) clearance. Upon completion, Ceretype will market the cleared product with imaging
contract research organization partners, academic researchers, and leading MRI vendors to
broaden utility of fMRI and improve the outcomes of clinical trials for groundbreaking
neuropsychiatric therapies.

Public health relevance
NARRATIVE A dearth of objective biological evidence in clinical trials impedes effective treatment development in neuropsychiatry. Functional magnetic resonance imaging (fMRI) has been a transformative tool for human systems neuroscience that holds promise as a solution, but enduring methodological challenges have limited clinical deployment. To address a need for reliable neurobiological evidence of treatment effects, Ceretype Neuromedicine proposes to develop an end-to-end advanced fMRI platform focused on improving sensitivity, reliability, and standardization for industry-sponsored trials of neuropsychiatric therapies through FDA 510(k) clearance of a class II software as a medical device. Upon successful completion, Ceretype will market its platform to de-risk, accelerate, and ultimately improve the outcomes of clinical trials for groundbreaking neuropsychiatric therapies.